Nutrient-sensor O-GlcNAc Transferase Regulation of Autophagy in Homeostatis of Pancreatic Beta-cell Mass and Function

PROJECT SUMMARY/ABSTRACT
O-GlcNAc transferase (OGT) is a nutrient and stress sensor protein highly expressed in pancreatic β-cells. This
enzyme exclusively catalyzes the post-translational glycosylation of target cytosolic and nucleic proteins (O-
GlcNAcylation). β-cell OGT knockout mice develop severe diabetic phenotype, suggesting that OGT is crucial in
shaping glucose homeostasis. The long-term goal of this research is to understand the mechanisms of how
protein O-GlcNAcylation shape β-cell health and function. O-GlcNAcylation, mTORC1 and AMPK signaling are
dysregulated in many diseases including Type 2 diabetes. Although we have made advancements in our
understanding of the roles of nutrient sensor proteins mTORC1, AMPK, and OGT by studying them
independently, how they crosstalk in vivo is largely unknown. Our research work for the past six years reveal
that OGT promotes optimal β-cell health through its ability to sense nutrient levels and orchestrate a cohesive
cellular response to maintain β-cell mass and elicit sufficient insulin release. In this current proposal, we will
test the main hypothesis that OGT elicits crosstalk with mTORC1 and AMPK, and their downstream
target ULK, to negatively regulate autophagy to maintain β-cell mass and function homeostasis. Diabetes
is associated with dysregulated autophagy in β-cells and interventions ameliorating autophagy homeostasis
could be beneficial in reducing functional impairments in islets caused by glucolipotoxicity. We will leverage
innovative in vivo models with increased or reduced function of OGT, mTORC1, AMPK, and ULK to test the
crosstalk among these nutrient-sensor proteins regulating autophagy-dependent β-cell function and
mitochondrial homeostasis. Specific Aim 1: To delineate molecular mechanisms through which OGT
regulates mTORC1 signaling in β-cells. Specific Aim 2: To delineate the role of OGT on autophagy in β-
cells. This new proposal is innovative because there are currently no studies linking OGT and mTORC1
crosstalk in pancreatic islets and their regulation of autophagy-dependent β-cell mass and insulin secretion. A
greater understanding of the complex interactions between major nutrient and stress sensors OGT, mTOR and
AMPK signaling is critical in optimizing β-cell health. Our results will reveal the central function of OGT as a
master orchestrator of nutrient signaling pathways in β-cells that may be valuable targets for β-cells preservation,
providing new therapeutic models for treating patients with diabetes.

Public health relevance
PUBLIC HEALTH RELEVANCE Type 2 diabetes (T2D) is a critical public health concern with high mortality rates due to increased risks for many major life-threatening pathologies that is largely driven by chronic hyperglycemia. In response to chronic nutrient excess such as hyperglycemia, inappropriate levels of autophagy (organelle breakdown/recycling) are observed and associated with pancreatic β-cell failure through unknown mechanisms. In this proposal, we will study the unexplored interactions among nutrient-sensor proteins (O-GlcNAc Transferase; OGT and mechanistic Target of Rapamycin; mTOR and AMP-activated Kinase; AMPK), and their downstream signaling contribution to β-cell mass and insulin secretion that are maintained through the process of autophagy, with the long-term goal of generating new therapeutic targets for β-cells preservation for treating patients with diabetes.